Chronic Renal Insufficiency Cohort (CRIC) Study Clinical Center

PROJECT SUMMARY/ABSTRACT
Since 2002, the NIDDK has sponsored four phases of the prospective Chronic Renal Insufficiency Cohort
(CRIC) Study, which enrolled a combined cohort of >5400 adults with chronic kidney disease (CKD) at seven
Clinical Centers across the U.S. to address the overarching goals of identifying risk factors for CKD
progression and clarifying the relationship between kidney dysfunction and the risks of subclinical and clinical
cardiovascular events, death, resource utilization and other patient-centered outcomes. The most recent
Phase 4 (ending June 2023) has further innovated on remote data collection methods and more granular
investigation of kidney function trajectories and cardiovascular sub-phenotypes across the spectrum of CKD
severity. The proposed CRIC Phase 5 will leverage the cumulative experience, expertise and success of the
CRIC Study network by creating mechanisms for future data collection and analyses and generating tools and
resources for ongoing use of the extensive longitudinal CRIC data and biospecimens. CRIC Phase 5 will
strengthen the existing unparalleled resource for the broader research community that will enhance the
science related to CKD to achieve the ultimate goal of improving clinical and patient-centered outcomes. The
Kaiser Permanente Northern California/University of California, San Francisco (KPNC/UCSF) Clinical Center
has been a leader within the CRIC Study and the Specific Aims to be addressed in CRIC Phase 5 by the
KPNC/UCSF Clinical Center are:
1. To complete clinical outcome ascertainment for the CRIC participants enrolled in the sub-protocols initiated
during Phase 4, including in-home testing of kidney function and damage and ambulatory measures of cardiac
arrhythmias and cardiovascular reserve
2. To complete follow-up of eligible CRIC participants
3. To conduct analyses that integrate the data collected through the Phase 4 sub-protocols with previously
collected data and outcomes to identify novel risk factors and sub-phenotypes for CKD progression,
cardiovascular and other outcomes
4. To facilitate linkages with external data sources to allow acquisition of additional data for future
investigations
5. To transfer data and collect and ship biological specimens to the CRIC Scientific and Data Coordinating
Center for transfer to NIDDK Central Repository to support future research
6. To promote dissemination of tools to facilitate the use of CRIC resources by investigators in the broader
scientific community during and beyond the end of the CRIC Study

Public health relevance
PROJECT NARRATIVE Chronic kidney disease is a significant and growing public health problem that currently affects an estimated >37 million Americans. The NIDDK-sponsored prospective Chronic Renal Insufficiency Cohort (CRIC) Study was established to identify factors leading to worsening of chronic kidney disease and to understand the complex relationship between kidney dysfunction, cardiovascular disease, death, and other clinical and patient- centered outcomes. The overall purpose of the proposed renewal of the Kaiser Permanente Northern California/University of California, San Francisco CRIC Clinical Center is to complete follow-up of its existing Phase 4 participants as part of the anticipated overall eligible CRIC cohort of >2100 adults with chronic kidney disease, with a focus on ascertaining clinical outcomes, creating mechanisms for future data collection and analyses, and generating tools and resources to facilitate ongoing use of CRIC data and biospecimens by the broader scientific community during and beyond the final phase of the CRIC Study.